BIOLOGICAL EFFECTS OF PARTICULATE ORGANIC MATTER

DESCRIPTION: (Adapted from the Investigator's Abstract) Particulate matter (PM) and its adsorbed contaminants are associated with adverse health effects, including an increased risk of cancer. The level of PM10, particulates 10 um or less, in the Paso del Norte (PdN) air basin regularly exceeds federal guidelines, potentially exposing people to harmful toxicants. To date, research has not been undertaken to study biological effects of PM locally. In the proposed study, PM filters will be collected from air monitoring stations in El Paso, TX and Juarez, Chihuahua; organic material will be extracted and evaluated for biological effects. Cultured hepatoma cells will be exposed to extracts to determine Ah receptor mediated biological activity. Ah receptor ligands are known to cause numerous adverse health effects. Further, extracts will be used in the Ames test for mutagenicity, with and without metabolic activation. Finally, cells will be incubated with extracts and DNA damage will be measured with the Comet assay. The results of the study will also compare the use of a number of cell types with the goal of identifying the most sensitive and cost effective model system. This study will provide valuable baseline data on the potential for adverse health effects of PM in an airshed that has received almost no scientific attention.